Control of stellate cells-driven liver cancer by the p62/NBR1 adapters

? DESCRIPTION (provided by applicant): The long-term goal of this proposal is to contribute to the understanding of the molecular signaling mechanisms whereby hepatic stellate cells (HSC) promote hepatocellular carcinoma (HCC) progression. Fibrosis and the inflammatory microenvironment are hallmarks of non-alcoholic steatohepatitis (NASH), and that are increasingly recognized as conducive to cirrhosis, HCC, and end-stage liver disease. This requires liver transplantation, and quite often is the next step in liver disease progression for a significant subset of patients with fatty liver (up to 10 million in the US). Therefore, the identification of the cellular and molecular factors that account for NASH development and how that leads to HCC is a major gap in the understanding of its pathogenesis. Recent results indicate that hepatic stellate cells (HSCs), which differentiate to myofibroblasts upon liver injur and orchestrate the production of extracellular components that form the fibrotic scar and inflammation, are central players in the control of HCC development. This proposal in based on our preliminary in vitro and in vivo studies in mice, and in the analysis of human HCC data sets, strongly suggesting that the signaling adapters p62 and NBR1 are critical players in NASH and HCC development, and that they act by regulating the function and activity of HSCs through a new paradigm involving the negative regulation of TGFβ signaling. Here we will test this hypothesis by addressing the following Aims: (Aim 1) Determine the molecular mechanisms of action of p62 and NBR1 in HSC activation at a cell autonomous level by: (1.1) determining the impact that NBR1 ablation has on TGFβ signaling in HSC activation; and (1.2) unraveling the detailed biochemical links between p62 and NBR1 with different components of the TGFβ signaling cascade. (Aim 2) Determine the contribution of the p62/NBR1 signaling cascade in HSCs to the control of NASH and HCC in cell-specific in vivo mouse models by: (2.1) characterizing HSC-specific knockout mice for p62 and/or NBR1 and determining their contribution to NASH and HCC development; (2.2) determining the signaling pathways altered by p62 and/or NBR1 deficiency in HSCs in vivo; and (2.3) determining the clinical relevance of p62 and NBR1 in HSCs. Results from these studies will serve to identify new biomarkers to predict the NAFLD-NASH- HCC transition, as well as new therapeutic targets for prevention and treatment of these liver pathologies.

Public health relevance
PUBLIC HEALTH RELEVANCE: Fibrosis and the inflammatory microenvironment are hallmarks of steatohepatitis (NASH), which is increasingly recognized as conducive to hepatocellular carcinoma (HCC). There are no effective treatments for NASH or HCC and it is difficult to identify the individuals who are at highest risk of liver disease progression from steatosis. Our preliminary data identifies p62 and NBR1 as a key step in this process by repressing the activation of hepatic stellate cells in the non-parenchymal tumor microenvironment. Here we will investigate in vitro and in vivo the regulatory signaling pathways that link p62 and NBR1 to TGFβ signaling, a key pathway in the activation of these cells, to identify new biomarkers and therapeutic targets.